Centromere Function and Dicentric Chromosome Stability

Chromosome inheritance ensures transmission of genetic and genomic information. Abnormal chromosome
number (aneuploidy) and altered chromosome structure cause birth defects, reproductive abnormalities, and
cancer. The centromere is the locus required for chromosome segregation and genome stability. Normal
chromosomes typically have only one centromere, but, genome rearrangements associated with birth defects and
cancer produce chromosomes in which two centromeres are physically linked. These dicentrics are not usually
tolerated in most model organisms, as originally illustrated in maize by Barbara McClintock nearly 80 years ago.
Paradoxically, dicentric chromosomes occur frequently in the general human population and are extremely
stable during cell division. A major impediment in studying dicentric chromosome formation and fate in humans
has been the absence of experimental systems. To circumvent this long-standing problem, we developed assays
to experimentally create dicentric human chromosomes that molecularly mirror those that occur naturally and
are biomedically relevant. We showed that in some of these de novo dicentrics, centromere inactivation occurred
by partial centromere deletion. However, many of our engineered dicentric chromosomes, particularly dicentric
X isochromosomes (dicXs), retain two active centromeres and are very stable. This finding appears to contradict
McClintock's model of dicentric fate. In this proposal, we will build on our previous studies of dicentric human
chromosomes by leveraging an inducible dicX assay system to explore molecular mechanisms governing stability
of dicXs that maintain two active centromeres. We will focus on three major areas of investigation: 1) defining
the molecular links between dicentric structure (i.e. inter-centromere distance) and centromere composition and
kinetochore architecture; 2) testing the roles of alpha satellite genomic structure and transcription in dicentric
stability, and 3) investigating mechanisms of centromere protein inheritance that result in varying centromere
configurations on dicXs. Our work will place specific genomic and epigenetics events on the timeline of dicentric
formation and stabilization by making use of a powerful chromosome engineering system that generates
dicentric chromosomes that precisely model those that occur frequently in humans. These studies will also be
critical for understanding dicentric formation and structure, refining long-established models of dicentric
stability, and providing new molecular insights into inheritance of centromere function in humans.

Public health relevance
Dicentric chromosomes are abnormal products of genome rearrangement that are associated with birth defects and drive tumorigenesis. Dicentric chromosomes in humans are unusual in that they are retained in the karyotype at high frequency, unlike dicentrics in most model organisms. It is perplexing that these dicentrics are not selected against since they are associated with birth defects and infertility. To better understand human dicentric chromosome formation and fate, we have established powerful experimental systems that re-create the two most prevalent types of dicentric chromosomes. With these assays, we discovered that half of newly produced dicentric chromosomes are stabilized by inactivating one centromere. However, the remaining dicentrics keep two active centromeres and are stable long-term. Based on dogma in the field, these latter dicentrics should be unstable. This research will focus on identifying the genomic and molecular basis for dicentric formation and the molecular mechanisms that affect centromere function so that the dicentric is retained and passed on to offspring